Comparative Modeling of Lung Cancer Prevention, Early Detection and Treatment Interventions

Project Summary Abstract
Lung cancer remains the leading cause of cancer related mortality in the US and globally—
responsible for ~1.8 million deaths annually. As collaborative investigators of the Cancer
Intervention and Surveillance Modeling Network (CISNET) Lung Working Group (LWG), we
have contributed to the development of US national strategies for reducing the lung cancer
burden by quantifying the impact of tobacco control on smoking, lung cancer, and overall
mortality, and by evaluating the population benefits and harms of lung cancer screening in the
US. Due to ongoing reductions in smoking in the US, lung cancer mortality is projected to
continue declining. However, lung cancer is still expected to result in over 4 million deaths over
the next 50 years. Thus, in addition to tobacco control efforts, a focus on early detection and
treatment interventions will be critical to further reduce the lung cancer burden in the US.
Moreover, as new tobacco products, such as e-cigarettes (e-cigs), become more popular, there
are concerns that the gains achieved in the fight against smoking could reverse. We propose to
continue our work and extend our models to assess the impact of 1) future tobacco control
interventions in the ever-changing tobacco market landscape, 2) improvements in lung cancer
screening and other emerging early detection strategies, 3) innovations in lung cancer
treatment, and importantly, 4) their synergistic interactions on lung cancer rates and overall
mortality in the US and globally.

Public health relevance
Project Narrative Lung cancer remains the leading cause of cancer related mortality in the US and globally accounting for 1.8 million deaths annually. As collaborative investigators of the Cancer Intervention and Surveillance Modeling Network (CISNET) Lung Working Group (LWG), we have contributed to the development of US national strategies for reducing the lung cancer burden by quantifying the impact of tobacco control on smoking, lung cancer, and overall mortality, and by evaluating the population benefits and harms of lung cancer screening in the US. This proposed work will extend existing CISNET LWG models to assess the impacts of future tobacco control interventions in the ever-changing tobacco market landscape, improvements in lung cancer screening and other emerging early detection strategies, innovations in lung cancer treatment, and their synergistic interactions, on lung cancer rates and overall mortality in the US and globally.